COVID Supplement: MAINTENANCE OF NIAID SPECIFIC PATHOGEN-FREE MACAQUE BREEDING COLONIES

This supplement will fund upgrades to facilities and equipment to enhance monitoring and housing of animals and to protect health pf animal and staff by reducing potential for SARS-CoV-2 transmission and spread within colonies.